Clinical Protocol and Data Management

CLINICAL PROTOCOL AND DATA MANAGEMENT
PROJECT SUMMARY/ABSTRACT
The Case Comprehensive Cancer Center (Case CCC) is committed to the translation of laboratory insights into
routine clinical care. This requires a deep infrastructure to support the conduct of clinical trials of new
interventions designed to prevent, diagnose and treat cancer, and improve the long-term outcomes for cancer
survivors. The Clinical Protocol and Data Management services of the Case CCC provide a centralized resource
for the oversight and management of clinical trials from concept development through reporting of study results.
Services include assistance with concept development and protocol writing; feasibility assessment; budgeting
and contracting; research nursing and data management; database development and oversight; regulatory
management including IND applications; interactions with sponsors; study registration; quality assurance; staff
education; and reporting of results. Data and safety monitoring to ensure the integrity of data and patient safety
is a critical centralized function. As our goal is to ensure access to clinical trials for all of our patients, special
efforts are undertaken to provide the opportunity to participate in clinical trials regardless of sex/gender, race,
ethnicity, socioeconomic status, or age. The Specific Aims are to:
1) Provide a highly efficient and coordinated infrastructure to assist clinical investigators in the development,
conduct and reporting of clinical trials.
2) Oversee data integrity and ensure the safety of patients who participate in clinical trials.
3) Provide access to clinical trials for all cancer patients regardless of sex/gender, race, ethnicity, age, and
socioeconomic status, and proactively identify and address barriers to clinical trial participation among
patients, providers, research staff, and healthcare systems.
4) Support a robust portfolio of research studies relevant to children and address special considerations for
children with cancer to facilitate their participation in clinical trials.
In 2016, 2,474 patients were enrolled onto Case CCC interventional trials (73 percent increase since 2012),
including 866 patients on treatment studies. In 2016, thirty one percent of accruals to treatment studies and
seventy percent of all interventional accrual was to investigator-initiated trials (peer-reviewed, institutional). There
is a substantial commitment to support of National Clinical Trials Network (NCTN) studies, with 209 patients
accrued to treatment intervention studies in the third year of the NCTN. Furthermore, in 2016 the Case CCC
enrolled and biopsied 93 patients on the NCI MATCH trial, supported by the Clinical Trials Units via rapid
activation, centralized registration, and coordination of tissue acquisition and processing.
!